Community outreach

PROJECT SUMMARY (PROJECT 2)
The goal of the WashU-UCSC-EBI based Human Genome Reference Center (HGRC) is to maintain and update
the new human genome reference produced by the Human Genome Reference Program (HGRP) and to provide
it to the scientific community. The goal of the HGRP Outreach and Education Center (HGRP-OE) is to
communication with the entire scientific and medical communities and disseminate data, resources, tools,
protocols, and educational materials. To support the HGRC and the entire HGRP consortium, we will provide
information to the community about the genome reference, obtain feedback from the community, and respond
to community needs. Towards this goal, we propose innovative and robust strategies that define how the HGRP
will engage with the broader user community. We will develop an HGRP web portal that serves as a user
interface for the new human genome reference and a resource repository for the associated data and tools. This
new resource will be tightly linked with many other genomic resources currently supporting biomedical research.
We will develop comprehensive strategies to train and update users on the current state of the reference,
including a comprehensive educational website, a suite of web-based training modules, seminars and webinars,
workshops at conferences as well as regional, traveling workshops, an HGRP APP for mobile devices, and
outreach via social media. Importantly, we will develop a transition plan from the current reference assemblies
(GRCh37 and GRCh38) to the new human pan-genome reference, and rigorously engage investigators and the
broader community to assist the transition. We present plans to proactively connect user feedback and respond
to it. If successfully implemented, our proposed HGRP-OE will greatly increase community awareness of the
new human genome reference and its usage, and thus maximize its use, value, and significance.